Immunology & Molecular Medicine Program Training Grant

This competing application for a training program in Immunology and Molecular Medicine (IMM)
supports the training activities of 18 field-leading scientists whose research centers on
immunobiology. The training faculty are all members of the Department of Molecular and Cell
Biology (MCB), and each has ample research support and a strong commitment to mentoring.
The training program is centered in the MCB Division of Immunology and Molecular Medicine, in
which most training faculty are members. The IMM Training program focuses on basic
immunological mechanisms in the context of infections, cancer, and immunopathology. We are
motivated by the shared belief that achieving a thorough, basic understanding of recognition,
activation, regulation, differentiation, and interactions of cells of the immune system will lead to
therapies for infectious disease, cancer and other ailments, and that training young investigators
in this approach, while providing broad training in basic molecular and cell biology, offers a most
productive avenue for enhancing success in this endeavor. The program is strongly committed
to recruiting and training students and postdocs from diverse personal backgrounds. The IMM
training program will provide a home for trainees in Immunology and Molecular Medicine and
support for training related activities. We propose support for 5 graduate students and 3
postdoctoral fellows. Graduate students will generally be supported starting in their second year
to ensure commitment to the research area and to provide additional information to evaluate
their capability of providing exceptional contributions to the program. Postdoctoral trainees will
generally be supported starting in their first or second year. In general trainees will be supported
for 2 years on the training grant, with additional years supported from other sources. While this
training grant recently completed its 10th year of funding, the grant is the successor of an NCI-
supported training grant (Molecular Immunology and Tumor Biology Training Program, T32
CA009179), which supported immunology research at Berkeley for 35 years.

Public health relevance
The relevance of immunology research to advances in public health has never before been so strong. This pre- and post-doctoral training program is committed to inculcating detailed understanding of the immune system as well as broad knowledge of molecular and cell biology and the principles of rigorous, elegant experimentation, in a manner that fosters innovative and inspirational contributions by the next generation of immuno-biologists.